Global Intracellular Responses to Mitophagy

PROJECT SUMMARY
Alzheimer’s disease (AD) and Parkinson’s disease (PD) are the most common age-related neurodegenerative
diseases where patients display a loss of cognitive function with dementia. AD and PD both have
neuropathological features widespread throughout the brain with protein aggregates made up of amyloid beta
(Ab ) and a-synuclein, respectively. Although AD is associated with Ab and tau deposits, aggregated Lewy
bodies in PD are comprised of a-synuclein and are also found in AD post-mortem tissue. Another commonality
between these diseases is that dysfunctional mitochondria, which provide energy to neurons, are some of
earliest detectable biochemical changes prior to excessive protein aggregation and neurodegeneration.
Selective autophagy pathways specifically target worn out or damaged organelles or protein aggregates for
degradation at the lysosome. However, why aren’t selective autophagy pathways such as mitophagy (removal
of damaged mitochondria) and aggrephagy (removal of protein aggregates) able to recycle or keep up with the
number damaged mitochondria and misfolded aggregated proteins in neurodegenerative diseases? The R35
parent award is working to understand how two biological processes: mitophagy and cell division are intimately
linked. The understanding of interorganelle connectivity and mechanisms to coordinate diverse cell behaviors is
lacking. To better understand the inheritance patterns of mitochondria during cell division, the parent grant aims
to interrogate the mechanisms enabling communication between damaged mitochondria and centrosomes
during mitosis. In this vein, one possible reason that mitophagy and aggrephagy mechanisms are not able to
protect the cell is that their regulation is negatively linked by shared adaptor proteins required for both processes.
Also, even though neurodegenerative disease aggregates such as TDP-43 and huntingtin are known to be
cleared by aggrephagy, dementia related aggrephagy clearance mechanisms are understudied. This 1-year
amendment application proposes to understand how mitophagy and aggrephagy are linked and either enhanced
or inhibited when stimulated by the events that precede neurodegeneration. Using primary neurons exposed to
a-synuclein preformed fibrils (PFF), we will induce a-synuclein aggregation and mitochondrial dysfunction. This
supplement proposes to: Characterize the dynamic flux temporal between mitophagy and aggrephagy in PFF
exposed neurons to determine their reliance on shared adaptor proteins. Perform quantitative proteomics to
discover other key components to aggrephagy induced by PFFs in neurons. Use optical clearing in whole brains,
to quantify aggregate formation and clearance by aggrephagy in PFF induced rodents genetically manipulating
autophagy pathways. This 1-year proposal will build the foundational work for future proposals to understand
mechanisms to manipulate mitophagy and aggrephagy to ensure both processes are working as efficiently as
possible to delay the progression of dementia related neurodegenerative diseases.

Public health relevance
This attachment is not required by the FOA, this placeholder is just to resolve system errors.